KF Supplement -- Sustainable and Optimized Cloud Resources on behalf of the Kids First Data Resources

PROJECT SUMMARY/ABSTRACT
The Kids First Data Resource Center (DRC) supports the development and deployment of cloud-based data
resources spanning >200,000 files across >30,000 participants. Beyond its dbGaP-integrated cloud storage
framework for data distribution, the DRC leverages AWS cloud-based resources that support a combination of
storage, computation, and cloud services resources that provide for a number of key functionalities of the DRC
including its data operations and harmonization framework, Portal data exploration/analysis features,
CAVATICA, PedcBioportal, and FHIR services. Under the proposed supplement the DRC will transition the
cloud management resources from the NIH STRIDES program to the DRC, ensuring continuity of cloud
resources and services.

Public health relevance
PROJECT NARRATIVE Under this supplement the Kids First Data Resource will provide the requisite continued support of the scalable cloud-based resources required for the continued operations and use of the Portal, associated services, CAVATICA, and additional AWS-hosted platforms. Support will also continue for data harmonization and integration across pediatric cancer and structural birth defect datasets, providing a unified discoverable framework for cross-disease research.